Advancing Conformance with the Voluntary National Retail Food Regulatory Program

Project Summary / Abstract The Voluntary National Retail Regulatory Program Standards (VNRFRPS) establish a uniform foundation for the design and management of state and local programs responsible for the regulation of retail food operations. The development and implementation of these program standards will assist state and local food safety programs to better direct their regulatory activities toward reducing foodborne illness hazards in retail food establishments. Based upon the Georgia Department of Agriculture 2011Strategic Plan and the July 10, 2012 Program Self-Assessment, program needs for the cooperative agreement application funding include: Hire a Retail Standards Manager to oversee the Retail Food Section's implementation and conformance with the VNRFRPS. Training and Standardization of the Retail Standards Manager. Retail food regulation rewrite to adopt the 2013 Food Code upon release by FDA. Standardization of retail field staff. Overhaul of the outmoded Field Inspection Manual with written operating procedures, policies, and MOUs required by the Retail Standards. Development of a quality assurance program to ensure consistent application of regulations, risk-based inspection frequencies, and the proper use of compliance/enforcement strategies; these are appropriate based upon the inspection findings. The Georgia Department of Agriculture has already made marked improvements to the Manufactured Food inspection program through our involvement with the Manufactured Food Regulatory Program Standards. If funded under this cooperative agreement application, the Department expects to make significant advances in conformance with the VNRFRPS, achieving program uniformity; and an enhanced focus on the risk factors that cause and contribute to foodborne illness.

Public health relevance
Project Narrative The overall goal of the Voluntary National Retail Food Regulatory Program Standards (VNRFRPS) is to provide a system for the operation and management of a retail food regulatory program focused on the reduction of risk factors known to cause or contribute to foodborne illness and to the promotion of active managerial control of these risk factors. Georgia will continue to strive toward full conformance with the VNRFRPS as we build capacity in a food safety program focused on public health, while working in collaboration with FDA and other stakeholders as part of an Integrated Food Safety System. __SpecificAimsTextDelimiter__ Specific Aims Goals of Proposed Project " Identify retail food program areas where we can have the greatest impact on retail food safety. " Promote application of effective risk-factor intervention strategies. " Promote active managerial control strategies targeted to risk factors associated with foodborne illness. " Identify retail program areas in need of attention and strategies to address these areas. " Develop and implement innovations administering the retail food program. " Improve industry and consumer confidence in food protection programs through uniformity within our own districts, and between state and local regulatory agencies. Summary of Expected Outcomes " Enhance conformance with the Retail Program Standards, to promote uniformity within an integrated national food safety system. " Constant improvement and advancement of the Retail Program Standards. " Develop strategies for achieving and sustaining conformance with the Retail Program Standards that can be shared and duplicated by other state and local agencies. " Provide the ability to implement innovative intervention strategies to reduce the occurrence of risk factors causing and contributing to foodborne illness, which can be shared and duplicated by other state and local agencies. Result of Proposed Project Significant to full conformance with the VNRFRPS sustainable after the cooperative agreement ends, resulting in protection of the public's health from foodborne illness and injury.